Smartphone phenotype collection for diagnostic screening of mild cognitive impairment

PROJECT SUMMARY
In this Phase II SBIR project, Parabon NanoLabs will complete the development, validation and
commercialization of CTX, a revolutionary smartphone- and tablet-based cognitive testing
platform for collection and analysis of measurements of cognitive performance (“phenotypes”).
Traditionally, cognitive assessments are performed in a clinic using either simple surveys that
assess only some aspects of cognition or expensive, single-purpose equipment such as eye tracking
stations. Such testing lacks the frequency and precision needed to detect subtle early changes that
signal the onset of mild cognitive impairment (MCI) or early-symptomatic dementia. Instead,
CTX will take full advantage of mobile sensors (e.g., audio, video, touchscreen, and motion) to
enable in-depth cognitive testing anytime, anywhere. Regular use of CTX will allow a clearer
picture of each user's cognitive abilities to emerge, enabling early detection of subtle changes. CTX
is not intended to replace neurologists but instead to extend their reach by allowing regular,
widespread screening for improved disease detection and patient monitoring. The long-range goal
of CTX is to allow aging adults to monitor and manage their cognitive health more effectively and
to provide pre-symptomatic indicators of pending dementia to patients and their clinicians, thus
enabling early intervention and planning.
After a highly successful Phase I project, CTX already enables rapid development of mobile tests
that can capture raw sensor streams in a synchronized fashion and transmit them to a cloud server
for subsequent analysis and reporting. Sophisticated analytics pipelines have been developed to
convert these sensor streams into cognitive phenotypes (e.g., extracting eye movement data from
selfie video taken during a cognitive test). Using the CTX framework, the Parabon team has
already developed an Apple® iOS® mobile app with proof-of-principle tests for assessing verbal
recall, eye movement, motor function, and episodic memory.
In Phase II, we propose to develop two new suites of CTX tests for one-time cognitive impairment
screening and cognitive performance monitoring, as well as phenotype extraction pipelines for
each. We will evaluate tests in normal and affected cohorts to determine usability, user retention
and whether resulting phenotypes enable accurate cognitive assessments by clinicians. Our
specific aims are to (1) Develop new and engaging cognitive tests and pipelines for assessing visual
search and targeting, expressive and receptive language, motor movement and episodic memory;
(2) Validate measures in cognitively normal and impaired cohorts; and (3) Analyze and prepare
data for publication and premarket submissions to the FDA.

Public health relevance
PROJECT NARRATIVE According to the World Health Organization, the number of people living with dementia is expected to triple from 50 million to 152 million by 2050. Existing pen-and-paper cognitive tests used for dementia screening were designed to detect overt disease, but early detection of cognitive decline is needed for proper intervention and planning. In this project, we are developing a smartphone- and tablet-based set of highly accurate tests that can be used for one-time cognitive impairment screening and game-like activities for ongoing cognitive health monitoring.